Associations of smoke from wildfires and prescribed burns with cardiorespiratory health outcomes in Reno, NV

ABSTRACT
Similar to other Western U.S. cities, air quality in Reno, NV is routinely impacted by smoke from wildland fires. Smoke
plumes contain complex air pollutant mixtures, and their aerosol composition is governed by several factors. These
factors include aging, in which secondary organic aerosols are formed when biomass burning emissions undergo
atmospheric oxidation, and fuel type (i.e., the type of vegetation burned). Residents throughout the West are also
exposed to smoke from prescribed burns, which are used by land managers to mitigate wildfire risks. Due to their lower
intensity, prescribed burns are more likely to smolder, and emissions from smoldering fires differ from those of flaming
fires. To model the aerosol composition of smoke plume mixtures in the West requires detailed emissions information
from regionally relevant fuels, accurate characterization of aerosol aging, and consideration of differences between low
intensity prescribed burns and flaming wildfires.
In 2006, the major health care provider in Reno (Renown Health) transitioned to electronic medical records (EMRs).
At present, this database contains information on over 1.4 million patient visits. This resource, combined with Reno’s
frequent exposure to smoke from fires that originate from ecosystems impacting many major Western U.S. cities, make
Reno an opportune setting to investigate associations between smoke plume mixtures and population health.
Our proposed study has two overarching goals. 1) We will improve smoke exposure modeling in the West for use in
public health applications. We will create a new, innovative air quality model that will be the first to use tailored
emissions information from regional biomass fuels to model smoke plume mixtures, which will vary according to the
ecosystem of origin, atmospheric aging, and fire intensity (low intensity prescribed burns vs. flaming wildfires). 2) We
will advance understanding of the acute population-level health effects of smoke exposures. We will perform an
epidemiologic investigation using the Renown EMRs, considering overall associations and potential heterogeneity by
smoke plume mixtures. We will estimate associations of smoke exposures with four broad categories of health
outcomes (acute upper airway disease, acute lower airway disease, acute cardiovascular disease, and maternal blood
pressure) and with specific acute conditions of a priori interest within these categories (i.e., asthma, bronchitis, COPD
exacerbation, pneumonia, congestive heart failure exacerbation, ischemic stroke, and myocardial infarction).
Anticipated outcomes include improving our ability to model smoke plume mixtures for biomass burning events that
impact millions of Americans annually and are projected to increase in the future. We will provide the first health
association estimates for prescribed burns, which will be of immediate use to land managers and other stakeholders in
the natural resources and public policy arenas. We will also provide the first estimates of potential heterogeneity in
population health outcomes by smoke plume mixtures. Longer-term, our study will help to inform the development of
more accurate, evidence-based public health warning systems.

Public health relevance
NARRATIVE Reno, Nevada is impacted by smoke plumes from wildfires and prescribed burns. We will measure and model the pollutants in these smoke plumes, and we will estimate associations of smoke pollutants with maternal, child, and adult acute health outcomes. Our goals are to improve smoke pollutant modeling for public health and to better understand the health impacts of different types of fires.